Molecular pathways affected by drugs that disrupt Na+ and lipid homeostasis in malaria parasites

Project Summary
In recent years, several chemically diverse compounds have been identified that target PfATP4, a P-type
ATPase involved in maintaining Na+ homeostasis in malaria parasites. Some of these compounds have
advanced to clinical trials. Thus, PfATP4-active compounds are among the most attractive new antimalarials
being developed to counter the continuing threat of drug resistance. Over the previous funding period, we have
discovered some dramatic alterations in parasite physiology that accompany a short 2 h exposure to PfATP4
inhibitors. These include: i) Rapid alterations in lipid homeostasis within the parasites with reversible
accumulation of cholesterol in the parasite plasma membrane (PPM); ii) Morphological changes resembling
premature schizogony; and iii) Massive dephosphorylation of parasite proteins that may underlie the metabolic
slowdown that follows PfATP4 inhibition. These observations reveal a collection of hitherto unknown interrelated
molecular pathways, disruptions of which result in parasite demise. We found that PfATP4 inhibition appears to
result in inhibition of PfNCR1, another druggable transporter, that is involved in maintaining lipid/cholesterol
homeostasis within the PPM. Reduction of cholesterol content of the RBC plasma membrane results in dramatic
expulsion of trophozoites from the host cell without the lysis of the RBC membrane. Remarkably, treatment with
either PfATP4 or PfNCR1 inhibitors prevents this expulsion. These studies suggest an active transport of
cholesterol between the RBC plasma membrane and the parasite. We found that trophozoite stage parasites
exposed to PfATP4 inhibitors for just 2 h undergo massive morphological changes that resemble premature
onset of schizogony events including the formation of inner membrane complexes, rhoptry-like structures and
karyokinesis. In addition, trophozoites undergo massive reduction of a large number of metabolites suggestive
of metabolic shutdown. We hypothesize that underlying all these events is a signaling cascade unleashed by
the influx of Na+ into parasite cytoplasm following PfATP4 inhibition. In support of this proposition, we found
dephosphorylation of a large number of proteins, prominent among which were molecules involved in DNA
metabolism, chromosome segregation and cell cycle processes. The complexity of events triggered by PfATP4
inhibition requires a multidisciplinary approach. For this purpose, we have recruited outstanding co-investigators
in consortium arrangements for the next funding period. Together, we propose to carry out the following specific
aims: i) Investigate the relationship between cholesterol dynamics and its role in fatty acid and lipid transport in
P. falciparum; ii) Explore the significance of dephosphorylation of proteins that follows PfATP4 inhibition; iii)
Examine the causes of metabolic slowdown following PfATP4 inhibition; iv) Derive structural information for
PfATP4 and PfNCR1 to understand molecular details about these validated antimalarial drug targets.

Public health relevance
In response to the need to prepare for emergence of drug resistant malaria parasites, several new antimalarials have recently been discovered that affect sodium homeostasis in malaria parasites. This project aims to understand the consequences of disrupting sodium and lipid homeostasis that lead to the killing of malaria parasites. This information would identify additional targets for antimalarial drug discovery by advancing our basic knowledge of malaria parasites.